Testing a Dual Mechanism Model of Adolescent Anxiety Development & Related Sex Differences

ABSTRACT
Anxiety disorders remain one of the most common forms of mental illness and the 6th leading cause of
disability worldwide. Anxiety pathology tends to emerge during early adolescence, and this process occurs
differentially between the sexes, with rates becoming 2- to 3-fold higher in girls (vs. boys) post-puberty. Thus,
identifying adolescence-specific factors that predispose towards anxiety disorders is crucial for identifying at-risk
individuals early, before trajectories crystalize, and for providing novel intervention targets. Interestingly, the
developmental course of anxiety is inversely related to the maturation of emotion-regulation capacity, with
decrements in capacity appearing during the transition into adolescence. We and others have proposed that the
development of adolescent anxiety is due, in part, to differences in the maturational trajectories of brain networks
supporting emotion regulation (i.e., emotion dysregulation is a key endophenotype for anxiety development).
However, the adolescent- and sex-specific neurobiological mechanisms that support the development of emotion
regulation, and their implications for the manifestation of anxiety pathology, are not well understood. We will test
a model incorporating two risk factors: pubertal testosterone and axonal myelination of prefrontal-subcortical
circuits. We will collect longitudinal (3 waves, each 1 year apart) multi-modal (e.g., diffusion, ultra-fast fMRI)
neuroimaging data from individuals at the transition into adolescence, half of whom are at high risk for developing
an anxiety disorder. Aim 1: We recently proposed a model in which testosterone dampens the effectiveness of
key emotion-regulation circuitry, whereas myelination of white matter in that circuit has the opposite effect. Aim
1 will evaluate this model by testing whether (i) increases over time in pubertal testosterone are linked to
functional decoupling between orbitofrontal cortex (OFC) and amygdala and (ii) this decoupling predicts emotion
dysregulation and consequent anxiety increases. This aim will also test whether sparser baseline myelination of
uncinate fasciculus (connecting OFC-amygdala) is linked to weaker functional coupling, higher dysregulation,
and anxiety. Aim 2: The biological mechanisms that confer greater risk for anxiety in females remain unknown.
Our work in healthy adolescents suggests that females have a higher sensitivity to testosterone in the OFC-
amygdala circuit, and there is some evidence of myelination differences in this circuit. Aim 2 will test whether
testosterone and myelination have a greater impact on emotion-regulation circuitry/pathological anxiety in girls.
Aim 3: It is critical to identify baseline biomarkers predictive of future anxiety development in order to detect at-
risk individuals before trajectories crystalize. Aim 3 will test whether testosterone and myelination can be used
to predict the emergence of future anxiety. In sum, this project aims to identify neural and hormonal mechanisms
responsible for the development of adolescent anxiety. This work has the potential for tremendous public health
impact by harnessing cutting-edge methods to uncover and validate novel risk trajectories for anxiety.

Public health relevance
PROJECT NARRATIVE Pathological anxiety, which remains one of the most common forms of mental illness, tends to emerge during early adolescence and does so to a greater degree in girls than boys. The object of this proposal is to identify the adolescent- and sex-specific biological mechanisms that increase risk for anxiety during adolescence, with a focus on testosterone and myelination of prefrontal-subcortical circuits. This research has the potential to significantly impact public health by identifying developmental pathways that increase risk for anxiety, which will enhance the identification and treatment of at-risk kids before trajectories crystalize.